Admin-Core-001

Abstract
The Administrative Core will provide administrative and fiscal management for all projects and cores in this HIPC program and facilitate and foster collaborative communications between investigators for internal and HIPC-wide interactions. This core will provide program-specific administrative support including coordinating frequent interactions between projects, organizing regular monthly meetings of all project and core investigators and personnel (alternating between electronic and in-person), overseeing expenditures and invoices, maintaining compliance, and coordinating activities for HIPC-wide events and opportunities, as well as follow up communications and documentation of the aforementioned activities. The roles of this core comprise three main service aims. For service Aim 1, the core will provide program-specific organizational support. The administrative staff of this core, overseen by the Program Director, will provide the necessary administrative support to coordinate the multiple groups in this program, including organizing regular meetings between project investigators and advisory groups. The administrative core will also assure regulatory and training compliance for this program. In service aim 2, the core will implement program-specific financial management, including the tracking of expenditures by all groups and subcontracts, ensuring timely submission of invoices, and enabling productive use of funds. In service aim 3, the core will facilitate HIPC- wide collaborations and initiatives for program investigators by providing specific support for inter-HIPC projects and submission of institutional opportunity fund applications. Through these aims, the administrative core will serve an essential cohesive function to coordinate all project and core investigators and activities in this program.

Public health relevance
Public Health Relevance The human immune response to virus infection is remarkably heterogeneous. The COVID-19 pandemic caused by the novel respiratory virus, SARS-CoV-2, revealed major gaps in our understanding of human antiviral immunity, and the different responses and susceptibilities between individuals based on age, sex, and other factors. This proposed program will advance our understanding of human immune responses to viruses and vaccines by studying tissue sites where immune cells reside and function to obtain a more complete assessment of the factors which control immune protection than can be measured in peripheral blood.